Project II

Project 2: Scalable in vitro gametogenesis for identifying genetic and epigenetic infertility factors.
This project seeks to advance the understanding of infertility by developing and deploying in vitro
gametogenesis platforms to identify underlying genetic and epigenetic causes. The field of reproductive
genetics has been severely hindered by challenges in distinguishing causative infertility alleles amongst
variants of unknown significance (VUS) identified by genome/exome sequencing. Our extensive use of mouse
modeling revealed that purely in silico pathogenicity prediction of infertility VUS have high false positive rates,
underscoring a need for scalable in vitro platforms for rapid screening of candidates. Speed and accuracy in
identification of causative variants is critical for clinical diagnostics and gene therapies – a goal of this overall
P50. Building upon a cytokine-free, transcription factor (TF)-based platform that we developed for simple and
scalable in vitro differentiation of mouse embryonic stem cells (ESCs) into primordial germ cell-like cells
(PGCLCs), this project proposes three interconnected aims to improve and deploy this system for accelerating
infertility genetics and epigenetics. First, missense VUS identified in non-obstructive azoospermia (NOA)
patients by Project 1, which correspond to PGC-expressed genes, will be screened in our mouse PGCLC
differentiation system. Additionally, we will develop human iPSC lines with TFs that enable similar scalability to
enable functional testing of human-specific VUS. Secondly, we will test VUS predicted to impact post-PGC
stages of gametogenesis by CRISPR-assisted gene targeting in ESCs that will be differentiated by: 1)
conventional methods involving co-culture of testis somatic cells with PGCLCs; 2) by engineering our scalable
platform for autonomous and more efficient differentiation of PGCLCs into meiotic stages; and 3) making 100%
chimeric mice that can be phenotyped directly. Third, the project will validate the impact of disruptions in
epigenetic genes on both mouse and human PGCLC development, with a focus on 25 candidates identified in
our CRISPR inhibition (CRISPRi) screen of 701 epigenetic genes. Additionally, we will test whether two widely-
used histone deacetylase inhibitors (the anticonvulsant valproic acid and dietary supplement sodium butyrate),
both of which mimic the effect of depleting the top hit NCOR2 in the PGCLC differentiation system, disrupt
PGC development in mice. Overall, the integrated approach is designed to accelerate the validation of infertility
variants and mutations that are flagged as being potentially causative by clinical sequencing. This will aid in
training computational models (Project 1) and accelerate the identification actionable targets for gene therapy
approaches (Project 3).

Public health relevance
Project II: Narative Despite remarkable advances in high-throughput sequencing and computational genomics, a major problem has been in developing tests to validate the predicted causality genetic variants amongst a sea of other variants in any given person. Whereas mouse modeling of human variants is a gold standard for variant validation, it is expensive and time-consuming, a problem exacerbated by the high false positive rate of in silico predictions. This project will deploy and further develop scalable in vitro gametogenesis platforms that have the promise of enabling functional assessment of large numbers of predicted infertility alleles found in the genomes of infertile patients, thereby enabling more rapid and confident clinical diagnostics and potential gene therapies.